Research Symposium in Clinical Aphasiology

Project Summary/Abstract
This application requests 5 years of additional support for a Research Symposium in Clinical
Aphasiology, to be held within the annual Clinical Aphasiology Conference (CAC). Aphasiology
is the study of aphasia, an impairment of understanding and producing language that results
from brain damage. The CAC is the oldest and most prominent scientific meeting dedicated to
research with clear implications for clinical assessment and treatment of aphasia and related
disorders. Between 120 and 150 participants attend CAC each year, each earning an invitation
by submitting an abstract of a completed research project. Participants include speech-
language pathologists, linguists, psycholinguists, (cognitive) neuropsychologists, and
neurologists who represent the world’s foremost investigators of clinically-relevant issues.
The goals of the Research Symposium in Clinical Aphasiology are to contribute: (1) to the
vitality of ongoing research in clinical aphasiology, via a coordinated set of keynote and
topically-related platform presentations; and (2) to the development of new investigators,
particularly students from traditionally underrepresented minority/ethnic groups. The bulk of the
proposed budget is to support travel expenses for 15 student fellows. These student fellows will
receive practice in presenting and discussing their own research or research plans, and will
participate in several specially-designed mentoring opportunities. Evaluations of past Research
Symposia have been highly positive and student participation at CAC has increased
substantially due to the grant.
The 2023 CAC (and Research Symposium in Clinical Aphasiology) is scheduled for May 30-
June 3 in a location to be determined. Invited speakers will present their most current work on
social determinants of health, and on community-based participatory research and social design
as applied to clinical trials of hearing care for older adults. The 2024 meeting will be held on
approximately the same dates in a location also to be determined, with a potential topic of
community-based approaches for addressing healthcare disparities. Potential topics for
subsequent years include include disability theory and social and cultural influences on
epistemological boundaries among researchers.

Public health relevance
PROJECT NARRATIVE Aphasia, a language disorder commonly caused by stroke, affects more than 2 million Americans and interferes with everyday communication, disrupts participation in work and preferred activities, and significantly reduces health-related quality of life. The proposed conference grant will support a set of cutting-edge presentations to help professionals improve the study and treatment of aphasia, with a focus on health disparities. The grant will also support student training in aphasia research and treatment.